PHYSICAL ACTIVITY OBTAINED BY CHILDREN DURING PHYSICAL EDUCATION CLASSES

My involvement in this study began prior to my coming to NICHD when I was a faculty member at the UTHSC School of Public Health. A random sample of school districts and schools at the elementary and middle school levels in one large Texas county were recruited and samples of students were observed during PE classes. I am involve in all aspects of the study, including study design, analysis, and publication.